Elucidating ECM Signaling in Cardiac Organoids with Machine Learning and Single-cell Multiomics

Project Summary
Extracellular matrix (ECM) is the most abundant biomaterial in the body. During cardiac development, the ECM
plays critical roles in the formation of shapes and patterns of the heart such as chambers and trabeculae through
elaborate interactions with differentiating cells. Although problems in ECM-cell interactions can lead to heart
diseases, signaling pathways activated by the specific ECM components are still poorly understood. We recently
succeeded in developing human induced pluripotent stem cell-derived cardiac organoids (iPSC-COs) that can
recapitulate cardiogenesis. In this multi-PI R01 proposal, our team will further elucidate the mechanisms of ECM-
cell interactions that influence cardiac differentiation and morphogenesis. We will apply machine learning and
novel iPSC double reporter lines (Tbx5-Clover2-Nkx2.5-TagRFP) to elucidate the effect of cell composition on
morphogenesis of iPSC-COs (Aim 1). Afterwards, we will screen 36 different combinations of ECM compositions
that can reliably induce iPSC-CO formation using 8 additional iPSC lines for validation (Aim 2). By rigorously
analyzing iPSC-COs made with optimized ECM using elastic property measurement and single-cell multiomics,
we will elucidate the biological and physical effects associated with ECM signaling and mechanotransduction at
single-cell resolution (Aim 3). In summary, understanding the exact role and mechanism of ECM-cell interactions
may contribute to finding new biomaterials or therapeutic modalities for treatment of heart diseases.

Public health relevance
Project Narrative Various types of extracellular matrix (ECM) play important roles in shape and pattern formation during cardiac development through dynamic interactions with cells. Our research team will create three-dimensional human embryonic heart models that mimic chamber formation, and utilize artificial intelligence (AI) and ECM microarrays to identify the ECM that most effectively induces chamber-shape formation. Then, we will analyze the biological and physical effects of the optimized ECM at single-cell resolution to elucidate the mechanisms of ECM-cell interactions for cardiac development.